The Institute for Health Equity Research Catalyst Center

PROJECT SUMMARY/ABSTRACT
Community engagement is fundamental to minority health and health disparities (MH/HD) research, helping to
ensure that scientific knowledge moves from inquiry and findings to tangible, sustainable impact. Building robust
community partnerships, novel dissemination strategies, and advancing the science of engagement are critical
activities for both aspiring and experienced MH/HD investigators. Few researchers, however, have the mentors
and networks needed to form strong, egalitarian partnerships, rigorously apply and assess engagement
strategies, and disseminate findings to scientific and non-scientific audiences. Catalyst will create a novel,
sustainable, scalable hub for community engagement research training, education, and multi-directional capacity
building accessible to researchers at all levels and across all disciplines. The Community Engagement and
Dissemination Core (CEDC) will address the engagement needs and interests of basic and translational
investigators with experience in MH/HD research and those new to this work. We will guide researchers who
employ a broad range of methods and study designs to develop or expand community partnerships and engage
multi-sector stakeholders to conduct MH/HD research in their areas of focus. In collaboration with the other
Cores, we aim to: (1) Convene a Catalyst Community Board (CCB) by building on existing academic-
community partnerships to support the development, implementation, and dissemination of MH/HD research.
We will unify two engagement approaches our team has been refining for nearly a decade: an Accelerator Model
in which distinct groups of community members and other stakeholders each focus on a specific community-
prioritized topic or health problem (e.g., environmental or mental health), and a Network Model comprised of
community leaders representing a population (e.g., justice-involved individuals) or a neighborhood (e.g., South
Bronx) experiencing high rates of disparities. (2) Cultivate community-engaged research capacity of Mount
Sinai investigators, community partners, and other relevant stakeholders. To support the Pilot Project Program,
we will contribute to all programmatic, training, and capacity building activities of the IDC, including input into the
pilot project solicitation, review of applications, study design and conduct, and development dissemination
strategies. To support the broader investigator community, CEDC and CCB members will participate in the
Consultation Service; relevant Health Equity Topics Seminars; sponsor an Annual Research Ideation Event to
brainstorm research topics and engagement strategies; and build new community-academic partnerships. (3)
Leverage novel participatory strategies to optimize dissemination of Catalyst-funded projects through our
boards and multi-level stakeholder networks, including 100+ NYC-wide community navigators we trained in
research literacy. CEDC will guide academic-community partners to co-prepare manuscripts and presentations,
host Policy and Payer Summits, and rigorously evaluate all CEDC activities. We will craft and disseminate a
Catalyst Center Blueprint to support adaptation of our strategies by others committed to advancing health equity.